Refining Trichomonas vaginalis treatment in women and men.

Abstract
Trichomonas vaginalis is estimated to be the most common non-viral sexually transmitted infection (STI). It
causes considerable and costly perinatal/reproductive morbidity, disproportionately affects persons of color,
and can amplify HIV transmission. After our two trials found multi-dose oral metronidazole (MTZ) to be superior
to single-dose 2 g oral MTZ, the Centers for Disease Control and Prevention now recommends multi-dose
MTZ as the treatment of choice for T. vaginalis in all women. Since neither trial included men and there is a
paucity of data in men, single-dose 2 g oral MTZ stands as the recommended treatment for men. In both
female trials, however, even though multi-dose oral MTZ was found to be superior to single-dose MTZ, multi-
dose MTZ still had unacceptably high rates of breakthrough infection (9%-11%). With approximately 2.6 million
cases of T. vaginalis per year in the United States, over 280,000 persons/year are estimated to be insufficiently
treated with multi-dose oral MTZ. Thus, there is a critical need to refine T. vaginalis treatment. Single-dose 2
g oral secnidazole (SEC), a next generation 5-nitroimidazole, may be a good option. Our recent trial found that
single-dose 2 g oral SEC was superior to placebo in T. vaginalis-infected women. Oral SEC has multiple
benefits compared to multi-dose oral MTZ including a longer half-life and improved tolerability. Single-dose
SEC poses less burden on the patient and can treat bacterial vaginosis, a common comorbidity among women
with T. vaginalis. On the other hand, MTZ is far less costly and can be given during pregnancy/lactation. The
overall goals of this multi-centered, randomized trial are to examine the effectiveness and cost-effectiveness
of oral multi-dose MTZ compared to single-dose oral SEC inboth women and men with T. vaginalis. Aim 1. To
examine the optimal treatment for T. vaginalis infection in women and men. This will be done by
conducting an open-label, randomized, multi-centered, parallel phase IV clinical trial comparing oral multi-dose
MTZ (500 mg BID for 7 days) to single-dose oral 2 g SEC for the treatment of T. vaginalis in women and men.
The test-of-cure (TOC) visit will be 4 weeks (± 1 week) after completion of treatment. We hypothesize that T.
vaginalis repeat infection rates at TOC will be 1.75 lower in the single-dose 2 g oral SEC arm versus the multi-
dose oral MTZ arm. Aim 2 To compare the cost effectiveness of multi-dose oral MTZ versus single-dose
oral SEC for the treatment of T. vaginalis infection. We will compare the direct and indirect costs of
treatment using either arm, taking into consideration the reproductive and perinatal outcomes associated with
T. vaginalis infection as well as increased risk for HIV-acquisition. We hypothesize the single-dose SEC will
have higher initial cost but will be more cost effective compared to multi-dose MTZ, largely due to lower
breakthrough rates. Data from these aims will fill critical gaps in the literature and provide data on refining the
treatment of T. vaginalis among women and men, with the long-term goal of reducing health disparities
attributable to this common infection.

Public health relevance
Project Narrative Trichomonas vaginalis is estimated to be the most common non-viral sexually transmitted infection worldwide (STI), causes considerable and costly perinatal/reproductive morbidity, and disproportionately affects persons of color; currently recommended treatment regimens have high breakthrough rates of infection. This proposal will examine the effectiveness and cost effectiveness of single-dose 2 g oral secnidzole compared to multi-dose oral metronidazole 500 mg twice daily X 7 days for the treatment of T. vaginalis in women and men. Results of this study will impact future Centers for Disease Control and Prevention STI Treatment Guidelines for T. vaginalis.